Vascular Regeneration with Human Pluripotent Stem Cell-derived Vascular Cells and Engineering Approaches

Project Summary
Ischemic cardiovascular diseases are the leading causes of morbidity and mortality in the USA. Despite
advancement in therapeutics, treating patients with severe conditions are still far from optimal. Recently, cell
therapy emerged as a promising option for those advanced cases for which no interventional or surgical
therapy is able to effectively revascularize the ischemic areas.
Human pluripotent stem cells (hPSCs), which include human embryonic stem cells (hESCs) and human
induced pluripotent stem cells (hiPSCs), have emerged as a promising candidate for vascular regeneration as
they have strong target cell differentiation capacity as well as paracrine effects. Thus, investigators have
developed various protocols to differentiate hPSCs into endothelial cell (EC)-lineage cells. We have developed
a fully defined, xenogeneic ingredient-free cell culture system that can generate purified functional endothelial
cells (ECs) at high yield. We further demonstrated that these hPSC-derived ECs (hPSC-ECs) have robust and
prolonged vessel-forming activities in vivo. However, one of the caveats of this approach is that their contribution
is mainly restricted to the capillary level without pericytes. For optimal vascularization, more stable and larger
vessels are also necessary. In previous cell therapy studies, this aspect was virtually unaddressed. Therefore,
we recently generated human PSC-derived SMCs (hPSC-SMCs) by using a defined culture system as well
and observed their contribution to vessel formation as vascular pericytes and SMCs.
Another important barrier for cell therapy is short-term survival of the transplanted cells. To overcome
this problem, we and others have investigated bioengineered cell therapy and demonstrated its effectiveness for
cell survival and function. However, uneven and localized distribution of the injected cells emerged as another
problem. Recently, we have developed a novel biodegradable hybrid copolymer consisting of gelatin and poly
glycerol sebacate (PGS), which was further made into a microbead form with alginate. We refer to this co-
polymer as AlGPM. This hybrid polymer is biodegradable and elicits minimal inflammatory responses. Moreover,
its microbead form promotes wide and homogeneous distribution of encapsulated cells in vivo.
Accordingly, in this study, we will address two unmet needs of the current cell therapy for ischemic
vascular disease. First, we will use both hPSC-ECs and hPSC-SMCs to induce formation of not only bare
capillaries but also pericyte-covered capillaries and SMC-covered arterioles. Second, we will develop a new
biomaterial that can enhance cell survival and distribution in vivo to maximize stable vessel formation and
therapeutic effects. Specifically, we will investigate whether a combination of these two cell types with
AlGPM hydrogel microbeads is able to exert the optimal effects on vascular regeneration. The long-term
goal of this study is to develop clinically applicable regenerative therapy using hPSC-derived vascular cells
combined with bioengineering technologies.

Public health relevance
Project Narrative Ischemic cardiovascular diseases are the leading cause of morbidity and mortality in the USA; however, clinical therapies that can grow blood vessels in the ischemic organs are currently lacking. Over the years, we have generated both endothelial cells and smooth muscle cells, which are essential components of the vessels, from human pluripotent stem cells (hPSCs) and have developed a novel composite biomaterial to enhance transplanted cell survival. In this proposal, we will determine the neovascularization and therapeutic effects of a combination of hPSC-derived endothelial cells and smooth muscle cells encapsulated in a new injectable biomaterial on tissue ischemia models.